A Network Science Approach to Conflicts of Interest: Metrics, Policies, and Communication Design

PROJECT SUMMARY (See instructions):
The primary purpose of this project is to develop new metrics and mechanisms for the evaluation of
conflicts of interest (COI) risks in the biomedical research enterprise. The innovation in COI risk
evaluation and communication will draw on a shift away from the conceptualization of COI as a problem
of individual researchers toward an understanding of COI as network phenomena. The pressing problems
of COI and the bias it inculcates stem not from individuals but from the aggregation of COI across
networks of researchers and funders. The research team will leverage machine-learning and high
performance computing to (1) track the circulation of COI within biomedical decision networks, and (2)
evaluate the extent to which certain conflict network profiles predict increased risks of patient harm. The
team will test candidate COI metrics with U.S. Food and Drug Administration's Adverse Events
Reporting System drug safety data. Using these data as a foundation, this project will also (3) develop and
evaluate strategies for communicating COI risks of bias designed to safeguard against the perverse
outcomes in current disclosure practices. The results of this research will underwrite novel evidence-based
recommendations for COI policies in biomedical research as well as recommendations for more effective
disclosure practices. To achieve these aims, this project will leverage machine-learning to identify systemic
COI networks within the biomedical research enterprises for specific drug products. The research team will
then evaluate to what extent network metrics predict relative increases in adverse event rates and severity
for identified products.

Public health relevance
RELEVANCE (See instructions): Concerns over the potential effects of industry funding and COI have been a recurrent feature in the study of the biomedical research enterprise and related clinical practice. Empowering researchers and policymakers with evidence-based approaches for the management of COIs in networks of research is essential for safeguarding the study of health and medicine and reducing the risk of negative effects on the practice of science and patients who rely on that science.